Virome Investigation in Diverse Human Populations

PROJECT SUMMARY/ABSTRACT (OVERALL):
The composition, diversity, and dynamics of all viruses found inside and on the human body–the human
virome–remains poorly understood. The goal of our Human Virome Program (HVP) Virome Characterization
Center (VCC) is to discover and curate the spectrum of viruses present in humans, and to characterize key
features of their biology and dynamics, including mapping viral tropism, monitoring changes over time,
identifying differences, and cataloging all phages. The VCC will leverage a combination of genomics,
transcriptomics, imaging, and computational approaches to develop a systematic, multimodal approach for
mapping and understanding the human virome and its diversity in precise detail and at scale. We will establish
a bespoke specimen collection for this purpose, leveraged from five existing large, longitudinal and diverse
cohorts that share a common study design, collectively encompassing >350,000 participants across all 55 U.S.
states and territories. From it, our Biospecimen Collection Core (BCC) will select a diverse 4,000-participant
cohort of varying ages, sex/gender, geographic origin, and racial/ethnic diversity, which will be processed by
the Biospecimen Analysis Core (BAC) using existing cutting-edge metagenomic and other omics approaches,
and as needed developing and adapting new methods to improve viral genome recovery and characterization.
The Data Analysis and Submission Core (DASC) will use state-of-the-art computational approaches to
process, store, analyze, and release these data. The Ethical Legal and Societal Implications (ELSI) core will
manage the responsible engagement with participants and explore how findings can be effectively
communicated to participants. The VCC, comprised of investigators from the Broad Institute, Brigham and
Women’s Hospital, and Harvard T.H. Chan School of Public Health, emphasizes effective leadership and
collaboration among its five cores. It will be led by a team of experts in diverse areas, including viral genomics,
the human microbiome, bioinformatics, technology development, and management of large cohort studies. The
Administrative Core (AC) will establish and implement the project plan with clear milestones, metrics, and
contingency plans to achieve its goals. The timeline encompasses participant engagement, sample retrieval,
data processing, and analytics, with ongoing evaluation and proactive measures to identify and address
potential challenges. The AC will also implement a Plan to Enhance Diverse Perspectives (PEDP) for the study
team and participants. The VCC is committed to rapid and open sharing of all resources generated, including
data, reagents, protocols, and tools, through public repositories, journals, and collaboration with other VCCs.
Through the project, we will develop an innovative and comprehensive approach to characterizing the human
virome, to understand what constitutes and modulates the virome and how it influences human health, and
disseminate the outcomes broadly to the scientific community and public at large.

Public health relevance
PROJECT NARRATIVE (OVERALL) Although viruses are often regarded as disease-causing agents, our bodies host a wide array of viruses, many of which likely even contribute to human health. We will leverage our large and diverse population cohorts and cutting edge viral genomics capacities to map and understand the human virome—the diversity and dynamics of all viruses found inside and on the human body—and its relationship to health and disease. Our findings will benefit public health by providing an unprecedented and systematic atlas of the human virome across individuals and time, helping to distinguish between harmless viruses and disease-causing pathogens, and ultimately enabling new ways to improve human health.